Elucidating the role of CHI3L1/YKL-40 in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Chitinase-3-like protein 1 (CHI3L1/YKL-40) is well known as a powerful biomarker for early detection of
neuroinflammation and Alzheimer’s disease (AD). While in peripheral tissues CHI3L1 has been well
characterized to regulate a wide range of immune and inflammatory responses, how it acts in the brain in the
process of neuroinflammation and AD development remains largely unknown. Recent evidence shows that
CHI3L1 is primarily secreted by activated astrocytes to signal a neurotoxic inflammatory response across major
brain cell types. The dynamic interactions between microglia, astrocytes and neurons are among the major
drivers for the inflammatory neurotoxicity underlying development of AD pathology. Disentangling such intricate
cellular cross-talk in human neural systems, and the role of CHI3L1 in this process, thus signifies a critical need
for developing therapeutics for AD and relevant neurodegenerative disorders. The long-term goal of my
laboratory is to understand the pathogenic determinants of neurodegeneration to inform treatments for AD. Using
human stem cell-based methodologies, the overall objectives in this application are: i) to define the signaling
mechanism whereby CHI3L1 governs glial activation and neurodegeneration; and ii) to develop the translational
potential of these signaling mechanisms to prevent neuronal damage in AD. Supported by our preliminary data,
our central hypothesis is that astrocyte-derived CHI3L1 functions as a signaling molecule to mediate
inflammatory responses in a cell type-specific manner – promoting neuronal degeneration and regulating
microglial inflammatory profiles. We also hypothesize that silencing neuronal CHI3L1 signaling will dampen
neurotoxicity and ameliorate AD pathogenesis. We propose to exploit iPSC-based pure and mixed human neural
cultures (microglia, astrocytes and neurons) to anatomize the inter-cellular interactions and rigorously test our
hypotheses. Three specific aims will be pursued to attain the overall objectives: in Aim 1, we will identify the
neuronal CHI3L1 receptor and downstream signaling pathway that convey the detrimental effects of CHI3L1 on
neurodegeneration in AD, using human neuronal cultures derived from isogenic control and multiple AD mutant
iPSC lines (from NIH-funded iNDI); in Aim 2, we will define the CHI3L1-modulated inflammatory properties of
microglia in AD, by control and AD mutant iPSC-derived human microglia; in Aim 3, we will decide the mechanism
of CHI3L1 function in astrocyte-microglial interactions for neurodegeneration in AD, aided by a reductionist
method to dissect the neuroprotective element out of the neuron-glial and glia-glial interactions of
neuroinflammation - the tricultures of human microglia, astrocytes and neurons generated from control and AD
mutant iPSCs. Our expected outcomes are to define an essential CHI3L1 signaling mechanism governing
neuroinflammation underlying AD neurodegeneration. This work will elucidate the biology of a prominent AD
biomarker, which will define a new path for AD/ADRD treatment and thus constitutes a significant positive impact.

Public health relevance
PROJECT NARRATIVE This proposed research is relevant to public health because defining the regulatory role of CHI3L1 for neuroinflammation in health and in disease not only greatly advance our knowledge on the non-neuronal contributions to the pathogenesis of Alzheimer’s disease (AD) but also present a proof of principle for forthcoming translational studies focusing on neuroinflammation. Developing strategies which target neuroinflammation to improve clinical outcome and alleviate disease impact are important as they are broadly applicable to a wide range of neurodegenerative disorders in addition to AD. Thus, this proposed research is relevant to the part of NIH’s mission that pertains to reducing the burdens of human disability.